Administrative Core

The Administrative Core (Dr. Rimsza) will provide the strategic leadership, organization, communication, and
fiscal management of the grant. The Core will support the grant through the following Specific Aims/Goals:
(1) To provide strategic leadership of the grant including the initiation, coordination, and successful submission
of this P01 grant, ensuring rigor and reproducibility in experimental design and core activities, and evaluating
on-going program announcements for additional funding for spin-off and developmental work. (2) To provide
feedback on progress and direction of Projects and Cores via requiring semi-annual presentations from each
Project and Core to evaluate their progress, discussing difficulties and planning new directions; convening the
internal Steering Committee and External Advisory Board, and monitoring and suggesting adaptations in
response to emerging scientific trends. (3) To coordinate communication by scheduling and running the
monthly LLMPP Steering Committee calls (setting the agenda, recording and distributing minutes), maintaining
membership list with contact information, organizing the semi-annual meetings (WebEx and face-to-face), and
preparing the annual progress report for the NCI. Communication functions will also include overseeing
preparation and submission of abstracts, posters, and manuscripts, including issues related to authorship.
Finally, the core will oversee any intellectual property issues (several patents were previously filed on behalf of
the LLMPP by the NCI); and (4) To oversee fiscal matters by working with PIs on the initial and 5-year budgets
and budget justifications, overseeing preparation of the sub-contracts to the different sites, monitoring
spending, approving invoices, and re-assigning funds as needed. Dr. Lisa Rimsza will be the Principal
Investigator of the Administrative Core and grant overall, as well as a co-PI on Project 1 and co-investigator on
Project 4. She has served as the LLMPP overall Principal Investigator for the last 7 years including
submission and successful funding of the prior LLMPP grant and spin-off grants, and is now leading the current
grant application after unanimous re-election as the continued overall Principal Investigator by the LLMPP
members. In addition to her scientific credentials, she is highly experienced in all aspects of scientific grant
management. The impact of this Core will be the smooth functioning of this already highly successful research
consortium, making the best use of resources and talent, and ensuring cohesion to achieve the stated scientific
and medical goals. She is supported by a strong infrastructure in the Office of Sponsored Projects
Administration at the Mayo Clinic including pre-award and post-award specialists, accounting, and liaisons with
the University of Iowa-Mayo Clinic Lymphoma SPORE grant’s Biospecimen shared resource.

Public health relevance
Narrative: The Administrative Core will provide the strategic leadership, organization, communication, and fiscal management of the grant. The Core will support all 4 Projects through ensuring rigor in experimental design, monitoring progress, promoting data and scientific exchange, and supervising spending. The overall purpose of the Administrative Core is to facilitate the proposed work of the grant, which is globally focused on expanding our knowledge of lymphoma in order to develop more successful treatments.